COBRE Center for Antimicrobial Resistance and Therapeutic Discovery

Project Summary: Overall
Resistance to antimicrobial therapies is a national and international crisis that threatens clinical practice from
fundamental primary care to the most advanced medical interventions such as cancer chemotherapy and
organ transplantation. Much of what we take for granted in clinical medicine could become too risky as
microorganisms have become increasingly resistant to our newest medications and our antibiotics of last
resort. Antimicrobial resistance also adds enormous costs to health care, exceeding $21 billion in the United
States alone. Compounding this problem is the fact that pharmaceutical companies have largely abandoned
antibiotic development programs. As an alternative to large pharmaceutical companies, academic institutions
and biotech startups can step in to refill the antibiotic pipeline using novel approaches to drug discovery. The
principal objective of this Phase I COBRE application is to build a unique, multi-disciplinary center of
excellence to study mechanisms of antimicrobial resistance and develop therapeutic countermeasures. The
long-term goal of the Center for Antimicrobial Resistance and Therapeutic Discovery (CARTD) at The Miriam
Hospital of the Lifespan Hospital Group is to develop new therapies for infections caused by drug resistant
pathogens. This long-term goal will be attained with shorter-term objectives of developing a new generation of
junior investigators who study mechanisms of resistance, characterize new targets, and study new and existing
compounds. CARTD will integrate their work with mentors and established investigators at the institution and
develop core facilities to enhance research capabilities in the field of antimicrobial resistance and the discovery
of new therapeutics. To achieve these objectives, the CARTD will complete the following specific aims: 1.
Consolidate existing researchers into a dynamic, interactive center of excellence across The Miriam Hospital,
and its academic partners in Rhode Island, including Brown University. 2. Foster the research programs and
career development of junior investigators in the field of antimicrobial resistance and studies of novel
therapeutic approaches. 3. Support new institutional research with pilot project funding. 4. Establish critical
infrastructure with new core laboratories to facilitate cutting edge research in antimicrobial resistance and
therapeutic discovery, and serve as a unique technical resources to other COBRE research programs, other
institutional researchers, and investigators in the region.

Public health relevance
PROJECT NARRATIVE: The ability of microorganisms to resist antibiotics and other therapies is approaching a crisis in clinical medicine. The Center for Antimicrobial Resistance and Therapeutic Discovery has been created to build a unique, multi-disciplinary center of excellence that investigates new ways to treat infections caused by microorganisms that are resistant to antimicrobials. The goals are to train and support new investigators in the field and provide state-of-the-art core services that enhance research into this important clinical problem.